Computer Modeled Multiportal Approaches to the Skull Base

DESCRIPTION (provided by applicant): Lesions of the anterior and middle skull base are diverse in their etiology and cause significant morbidity due to close proximity to the carotid arteries, brain, orbits, optic nerves and chiasm. For most lesions, a surgical biopsy, excision, or debulking is an essential aspect of treatment. Technological advances over the past few decades now permit transnasal endoscopic surgical access in many instances, which has dramatically reduced the morbidity of gaining surgical access compared to an open craniotomy approach. However, transnasal access is not sufficient for all lesions, which require an open craniotomy if lateral structures are involved. The geometric constraints at the pyriform aperture limit the angle between instruments to 15 degrees when manipulating a target at a depth of 9 cm on the skull base. To improve the ability to manipulate a target, one option is to widen the angle between instruments by using additional surgical portals. Many portals are described to access the skull base, but little work has been done on combining different portals in order to optimize an approach for a certain target location; portals include transnasal, transoral, transorbital, supraorbital, transmaxillary, transcervical, and transventricular. A multidisciplinay team of engineers and surgeons from subspecialties including otolaryngology, neurosurgery, urology and robotic surgery, and orbital surgery has been assembled. Within the team are professors, attending surgeons, engineering graduate students, and resident surgeons in training. We aim to develop an improved 3D computer model to identify and test optimal approaches for endoscopic access and excision of skull base lesions. Using individualized imaging information, it will offer preoperative surgical rehearsal to improve surgical outcomes and minimize adverse effects. Initially, clinically relevant skull base targets around the pituitar will be defined as locations where tumor invasion often occurs. Virtual endoscopy will be performed to access the specified skull base targets through a variety of endoscopic approaches, including existing standard endoscopic approaches and novel multiportal approaches. The multiportal approach provides wider angles between instruments, which will accommodate current surgical robotic platforms. The model will be validated in cadaver specimens and robotic feasibility will be assessed on two robotic surgery systems. We will use this model to test the hypothesis that multiportal approaches significantly broaden the angle of access to the target and minimize the probability of instrument collisions on set protocols of dissection. It is anticipated that the computer model will demonstrate the shortest, most direct, and least traumatic pathways to skull base targets. Normative data on the approach combinations will be generated and ultimately, these results will serve as a platform for future robotic integration and computer simulation into skull base surgery.

Public health relevance
PUBLIC HEALTH RELEVANCE: The relevance of this research proposal is to improve outcomes in patients requiring surgery of the brain and skull base. Traditionally, surgery in this area is associated with significant risks including paralyzed nerves, bleeding, cerebrospinal fluid leak, and decreased function of the eyes. The proposed work offers new surgical methods that incorporate novel technology so that the same surgery can be performed, but with less risk of injury to important structures and with improved recovery times postoperatively. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Surgery for skull base tumors is relatively common; there are 30,000 new skull base tumors each year in the United States alone. Many of these are resected through an open craniotomy. Unfortunately, this type of surgical access to skull base lesions often creates significant morbidity. Newer endoscopic approaches reduce this morbidity, decrease operative time, decrease recovery time postoperatively, and possibly obviate the need for an open craniotomy to access certain skull base targets. Yet current endoscopic approaches are limited by narrow portals to the skull base (e.g., nasal aperture). Combining multiportal approaches offers promise to improve surgical access while continuing to minimize adverse effects, but testing these complex approaches is challenging. We aim to develop a 3D computer model and algorithm that helps identify and test the optimal approaches for endoscopic access and excision of skull base lesions in patients. We propose three specific aims: 1) Develop a 3D computer model of the skull to measure approach angles and access to specified target locations. 2) Determine the optimal combination of surgical approaches to improve surgical manipulation and visualization at clinically significant target locations, including portals that permit robotic surgery integration. 3) Validate the computer model in cadaver specimens and test robotic feasibility on the skull base. We will use this model to test the hypothesis that multiportal approaches significantly broaden the angle of access to the target and minimize the probability of instrument collisions on 11 specific target locations for 20 established surgical approaches. It is anticipated that the model will demonstrate the shortest, most direct, and least traumatic pathways to skull base targets. We will derive optimized approach solution(s) for each of the targets defined around the pituitary gland and will generate normative data on the approach combinations based on 12 cadaver CT scans. The technique and software we develop will permit individualized preoperative rehearsal and approach planning. These steps will serve as a platform for integrating robotic tools into skull base surgery, which will be tested on cadaver specimens using the da Vinci and Raven robotic systems.